Investigations of Neuronal Ensembles and Shank3-Homer Scaffolds on Reward and Social Behavior in a Shank3 model of Autism

PROPOSAL SUMMARY
Deficits in social interaction are characteristic of several neuropsychiatric disorders, including Autism
Spectrum Disorder (ASD). The cellular, molecular, and circuit mechanisms of social deficits in ASD are largely
unknown and warrants further research. One of the most consistent etiological findings in ASD is a complete
deletion of the SHANK3 gene, which encodes a postsynaptic scaffold protein in neurons. Our lab developed the
first Shank3 complete knockout model by deleting exons 4-22 (Shank3∆e4-22). Shank3∆e4-22 mice show decreased
social and reward-seeking behavior and blunted response of the Nucleus Accumbens (NAc) to social cues.
The NAc is a well-established regulator of social behavior. Yet, the characteristics of neurons in the NAc
that are active during social behavior, or social ensembles, are not well defined. ~95% of neurons in the NAc are
medium-spiny neurons (MSNs) that express either dopamine receptor D1 (D1+), which encode reward
reinforcement, or D2 (D2+), which encode aversive responses. NAc MSNs express high levels of SHANK3, and
Shank3 deletion induces profound changes in D2+ MSN function. Taken together, this indicates a potential
mechanism of action for social behavior deficits in Shank3∆e4-22 mice.
SHANK3 scaffolds HOMER1b/c and metabotropic glutamate receptor 5 (mGluR5) to the postsynaptic
density (PSD). HOMER1b/c and mGluR5 function in the NAc is crucial for regulating social and reward-seeking
behaviors in WT mice. To study the role of SHANK3-HOMER1b/c interaction, our lab generated the first
SHANK3-HOMER1b/c mutant mouse, Shank3PL. Since joining the Jiang lab, I have collected pilot data showing
that Shank3PL mice have significantly decreased social and reward-seeking behavior. Pilot data also indicate
Shank3PL mice have decreased HOMER1b/c expression in the PSD of the NAc.
The specific objective of this proposal is to delineate how SHANK3 deficiency causes cellular and
molecular malfunctions that underlie abnormal circuit and social behavior using our two novel mouse models:
Shank3∆e4-22 and Shank3PL. First, I hypothesize that NAc social ensembles in Shank3∆e4-22 mice are primarily
composed of D2+ MSNs and encode aversion and negative sociability; in contrast, I predict WT social
ensembles are predominantly D1+ MSNs and encode reinforcement and positive social behavior. Second, I
hypothesize that SHANK3-HOMER1b/c scaffolds are crucial for social and reward behavior. We will test these
hypotheses using comprehensive methodologies.
This study will be the first to characterize social ensembles in a well-validated genetic ASD model and
the first to investigate the role of SHANK3-HOMER1b/c scaffolds on behaviors and NAc activity. Importantly,
these studies may lead to the identification of novel therapeutic targets for treating social and reward deficits in
ASD and other neuropsychiatric disorders.

Public health relevance
PROJECT NARRATIVE Mutations in the SHANK3 gene are a well-established risk factor for ASD. This proposal aims to delineate how SHANK3 deficiency causes cellular and molecular malfunctions that underlie abnormal neural circuitry and social and reward behaviors using two novel mouse models. These studies may lead to identifying novel therapeutic targets for treating social and reward deficits in ASD and other neuropsychiatric disorders.